Advancing Functional Assessment of Pediatric Flatfoot Using Weightbearing CT

Project Summary
The foot is a complex structure and severe deformities such as ﬂatfeet are common among children,
particularly those with neurologic disorders. Treatment of pediatric foot deformities is currently limited by
the inadequate visualization provided by standard of care 2D radiographs. These radiographic images are
limited to a single point of view and flatten irregularly shaped, 3D foot bones into 2D objects. Weightbearing
computed tomography (WBCT) is an emerging technology that allows for full volumetric assessment of the foot
in weightbearing with equivalent or less radiation exposure than a current standard of care foot & ankle
radiograph series. International experts have called WBCT a “game-changer” due to its ability to observe
pathologies in the adult foot previously not able to be seen including subtalar joint alignment, impingement, and
subluxation which have important clinical implications. WBCT has advanced knowledge of foot and ankle
morphology with a consensus for its use in adult symptomatic pes planus/flatfeet. Despite the successes and
changes in clinical paradigms resulting from the technological advances of WBCT, its applications have been
limited to adult foot deformity and have not been translated to pediatric populations, creating a large knowledge
gap in our understanding of foot pathologies throughout growth and development. Planus deformity, with
reported incidence as high as 44% of children, is of particular interest due to lack of understanding in structural
changes that may cause pain and dysfunction later in young adulthood. Our overall objective for the current
multisite project is to complete a comprehensive study of the 3D structure and function of pediatric planus feet.
To accomplish this goal, we propose two specific aims. Specific Aim 1 to complete a cross sectional evaluation
of children with planus foot deformity using current standard-of-care 2D radiographic analysis and equivalent
metrics obtained from 3D WBCT. We will also explore relationships between joint form and function. Specific Aim
2 is to complete a longitudinal evaluation of children with planus foot deformity to determine radiographic and
functional metrics that are predictive of worsening symptoms and arch collapse. The long-term focus of this
project is to provide a more comprehensive assessment of the 3D structure and function of planus foot structure
in children. This will allow for accurate clinical assessment and targeted treatment planning through improved
radiographic measurements and the ability to diagnose these complex foot disorders in developing children.

Public health relevance
Project Narrative Flatfoot deformities are common in children and can progress throughout the lifespan resulting in pain and disability, but current 2D radiographs provide inadequate visualization for proper assessment and treatment. The proposed research will provide a comprehensive evaluation of children with flatfoot foot deformity to determine radiographic and functional metrics that are predictive of worsening symptoms and arch collapse. Improved assessment of weightbearing foot structures in combination with dynamic gait data in children with foot deformities will allow for a more informed decision-making process for clinicians providing care, ranging from tone management, orthotics prescription, and surgical interventions.